Mechanism of chromatin accessibility, 3D chromosome organization, and their functions in gene regulation

Abstract of Parent Award:
(R35 GM139654 “Mechanism of chromatin accessibility, 3D chromosome organization, and their
functions in gene regulation”)
Tightly controlled gene expression is essential for the fitness and development of all living organisms, with mis-
regulation often leading to disease. Chromatin accessibility is a key factor of gene regulation in eukaryotic cells,
where nucleosome positioning can either promote or inhibit transcription. Assay for Transposase-Accessible
Chromatin with sequencing (ATAC-seq) and Micrococcal Nuclease with sequencing (MNase-seq) are two wild-
used high-throughput methods for evaluating chromatin accessibility. Although both techniques rely on similar
principles and theoretically should yield comparable open chromatin regions, our preliminary studies of published
ATAC-seq and MNase-seq data reveal substantial discrepancies. Specifically, out of the 4,800+ nucleosome
depleted regions (NDRs) identified by MNase-seq in the Saccharomyces cerevisiae genome, less than half are
detected as accessible by ATAC-seq. Given the popularity of these methods, a robust comparison is needed to
improve the interpretability of their results. To address this, we will perform MNase-seq and ATAC-seq on
matched samples and conduct a detailed bioinformatic comparison, investigating potential biases related to
sequence composition, NDR size, and associated factors (Aim 1). Furthermore, to enhance ATAC-seq's
sensitivity to small accessible regions, we propose a modified version termed single-hit (sh)ATAC-seq (Aim 2).
By sequencing single instead of double-tagmented fragments, this approach will significantly improve the
detection of short open regions. Together, we expect the research proposed here to result in more robust
measurements and interpretations of chromatin accessibility in future studies.

Public health relevance
Project Narrative: Chromatin accessibility is a crucial factor in gene regulation, and its dysregulation can contribute to disease. A more rigorous interpretation of genome-wide accessibility data obtained through ATAC-seq and MNase-seq will further our understanding of gene regulation and have significant implications for human health.